Training in Gastroenterology

The long-term objective of the Vanderbilt Training in Gastroenterology T32 Program is to provide trainees
with a rigorous scientific foundation in 1) basic research, in order to develop a deeper understanding of
gastrointestinal pathophysiology, reveal new disease mechanisms, and identify novel therapeutic targets, or 2)
clinical/translational research, through formal studies in clinical science or epidemiology. Our overall
hypothesis is that the most effective mechanism to impact digestive diseases is through cultivation and
support of an alliance of collaborative biomedical trainee and preceptor investigators operating within a vibrant
academic environment that catalyzes mutually reinforcing interactions. Our vision is to continue to inspire
interest among our trainees in the study of digestive diseases and for them to perform paradigm-shifting
science that translates to benefit for the patients and communities we serve. Dr. Richard Peek (Director,
Division of Gastroenterology) serves as Program Director. He will be assisted by an Associate Director, Dr.
Keith Wilson, former Director of the Adult Gastroenterology fellowship program, as well as a Steering
Committee and Internal and External Advisory Committees composed of senior faculty deeply invested in
training young investigators. This program is designed to support postdoctoral fellows (M.D., M.D./Ph.D.,
Ph.D.) who show exceptional aptitude for pursuing an academic career. Postdoctoral trainees are selected
from a curated pool of fellows accepted into the Adult and Pediatric GI training programs, physician-scientist
applicants from various other clinical training programs at Vanderbilt and applicants that apply to preceptor
laboratories. A customized mentoring team is constructed for each trainee consisting of a Mentor with
nationally recognized expertise and a Research Advisory Committee to provide additional guidance, mentoring
and feedback. The trainee's experience is enriched by interactions with other investigators and trainees, an
extensive program of seminars and conferences, and coursework tailored to meet individual needs. Based
directly on trainee demand, we have created the Academy of Investigators to provide comprehensive career
development and support to trainees on this T32. The unique environment that supports digestive disease
research at Vanderbilt, consisting of rich collaborative interactions between basic and clinical researchers, a
wide range of supporting Cores and Centers, robust institutional support, and exposure to state-of-the-art
clinical care, provides an outstanding opportunity to train successful scientists whose discoveries regarding
fundamental aspects of digestive diseases can be rapidly translated into improved patient care.

Public health relevance
The goal of this training program is to develop scientists with strong commitments to academic biomedical research in the area of digestive diseases.!